DECODE: Diagnostic Excellence Center on Diagnostic Error

Abstract
We plan to establish a Diagnostic Center of Excellence that will focus on reducing diagnostic errors related to
diagnostic imaging in two ways. We will: 1) implement a highly reliable and resilient system to enhance safety
by reducing failures in timely performance of clinically necessary diagnostic imaging examinations and
interpretative errors (Safety 2), and 2) improve diagnostic precision by building consensus using available
evidence around four common causes of diagnostic errors – findings that may lead to a diagnosis of lung,
prostate, pancreas and adrenal cancer. The DCE will build on strong pre-existing research and operational
collaboration between a team of safety scientists, biomedical informaticists and health services researchers at
the Massachusetts General Brigham (MGB) Health System. MGB is comprised of 2 tertiary academic
hospitals, 7 community acute care hospitals, 3 specialty hospitals, multiple ambulatory care and outpatient
imaging facilities serving patients in ambulatory, inpatient and ED settings, with a provider network of over
10,000 employed and affiliated primary care and specialty care physicians. Recent integration at MGB has
prioritized clinical integration, creating a single Office of the Chief Operating Officer, a single Office of the Chief
Medical Officer, and a single Enterprise Radiology governance including for quality and safety. We will
enhance a set of pre-existing limited implementation information technology-enabled functions and workflows
before MGB-wide expansion to address multiple types of diagnostic errors, including those leading to missed,
incorrect, or delayed diagnoses. Enhancements will improve EHR-integration, monitoring and learning
capabilities of our Clinical Dashboard to better address health disparities, to help advance an equity-informed
resilient system and associated workflows. Another system for Peer Learning will also be implemented to
target interpretive errors in diagnostic imaging. Finally, we will convene a multispecialty team of clinicians to
build consensus on recommendations for diagnosis and management of findings that may lead to lung,
prostate, pancreatic and adrenal cancer based on available evidence using a Modified Delphi process.
Evidence that are agreed upon will be embedded in a clinical decision support system that will be integrated
with the electronic health record. All specifications for systems and workflow processes, consensus results,
and lessons learned will be disseminated broadly through national conferences and meetings, a public
website, networks of clinical practice and institutions, and social media.

Public health relevance
Public Health Narrative We will establish a Diagnostic Center of Excellence focusing on decreasing diagnostic errors in medical imaging by implementing and evaluating a highly resilient system for care planning and coordination, as well as a peer learning system for clinical providers. In addition, we will seek consensus on evidence-based recommendations to enhance diagnosis of four targeted diseases – lung, prostate, pancreas and adrenal cancer. Combined, these initiatives may help reduce delayed, wrong, or missed diagnoses that contribute to poor patient outcomes.